Identifying the Causes of the Stagnation in National U.S. Cardiovascular Disease Mortality

PROJECT SUMMARY
Since 2010, U.S. life expectancy improvements have stalled and in certain years declined. Much
attention to this stall has focused on the role of rising drug overdose deaths. In published work, however, our
team has identified stagnating declines in cardiovascular disease (CVD) mortality to be the major culprit. A
failure to improve CVD mortality puts the U.S. at risk for sustained declines in inter-generational life
expectancy. However, to date, research has not identified why U.S. CVD mortality is stagnating and, for some
age groups, increasing. Using novel approaches, we will investigate four hypotheses for stagnating CVD
mortality: (a) rising obesity and the resulting increase in CVD risk at a national level, (b) plateauing declines in
cigarette smoking, (c) survivor effects attributable to improved survival among those with a history of a CVD
event, and (d) rising levels of socio-economic vulnerability and geographic disparities.
Aim 1 identifies the role that changes in obesity (Aim 1a) and cigarette smoking levels (Aim 1b) are
having on national-level CVD mortality. We will reconstruct cohort histories of obesity to model the aggregate
effects of both current and earlier-in-life obesity incorporating the dynamics of obesity duration in the
population across time. We will provide the first estimates of the role of slowdowns in the decline in cigarette
smoking use to CVD mortality trends by extending the Preston Glei Wilmoth approach to cause-specific
mortality. We will also apply g-method approaches to identify the joint effects of obesity and smoking
accounting for the dynamic relationship between the two variables. We will provide new estimates of the
changing prevalence, treatment, and control of three other established CVD risk factors (diabetes,
hypertension, high cholesterol) (Aim 1c). Aim 2 investigates “survival effects”, namely that improved survival
among those with a history of stroke or a heart attack have accumulated in the population raising the overall
frailty of the population. We will apply a novel simulation to quantify its role. Aim 3 turns the lens to disparities
and provides an in-depth accounting of heterogeneity in recent CVD trends by geography, race, nativity and
socioeconomic status. Examining subpopulation heterogeneity will reveal whether patterns of CVD mortality
align with those of diseases of despair. We will apply the methods developed in Aims 1 and 2 to account for
disparities in levels and trends in CVD mortality across population subgroups. We will also explicitly investigate
the role of the shifting population composition of the United States with respect to nativity and race/ethnicity.
The stagnation in U.S. CVD mortality declines has now been evident for a decade without a clear
explanation. The COVID-19 pandemic may only worsen existing trends. Given the magnitude of the change in
the CVD mortality trajectory and the fact that it is now affecting Americans of most age groups indicates that
more than one causal factor is responsible. This project will be a comprehensive and rigorous treatment of
leading explanations for the stagnation.

Public health relevance
PROJECT NARRATIVE Since 2010, death rates from cardiovascular disease in the United States have failed to improve. Research has not identified why death rates from cardiovascular disease are stagnating and, for some age groups, increasing. Using novel statistical approaches, this research will provide key insights into this public health issue with the objective of informing policy.